Pilot and Feasibility Program

PROJECT SUMMARY/ABSTRACT The Pilot and Feasibility Program (P&F) has been highly successful. Since its inception in 2007, the Center has funded 23 projects. A review committee consisting of UT Southwestern faculty as well as external reviewers selected the best applicants. This solicitation and review process was successful as evidenced by the excellence of our awardees. To date, the support provided by the Pilot and Feasibility program has resulted in 41 abstracts, 20 peer reviewed publications, and 27 grant applications. Our awardees were successful in obtaining extramural research support after receiving their P&F grants. Since 2011, the 8 P&F grant awardees who completed their grants have received 4 R0-1's, 2 K08's, and 4 other extramural grant awards. This count does not include the two grantees who received their grants in June, 2015, and have not yet finished their pilot projects. They established long-lasting collaborations with other O'Brien investigators which will further their career development and enrich nephrology. We now request funding to continue this successful P&F Program.